Research Training in Immunology

ABSTRACT
Immunology was a key element in the development of scientific medicine, and has since been a constant
source of extraordinary discovery that enriches every area of contemporary biomedicine from basic science to
translational and clinical research. Immunology established the foundation upon which our understanding of
infectious disease and vaccinology has been, and is being, built. As immunology pervades all of biomedical
science, so do a wide swath of biomedical disciplines support contemporary immunology. Microbiology,
molecular biology, cell biology, and computational biology among others are essential strands in the fabric of
immunology. This dually-distributed nature of immunology represents an extraordinary achievement for the
field, but simultaneously presents a challenge in training the next generation of innovators and scientific
leaders.
We propose to continue our successful Immunology Training Program (ITP), now completing its 30th
year of producing accomplished immunological researchers, preserving the factors that have contributed to its
success and draw on the specific strengths of Boston University and the Boston Medical Center, while
adapting to the changing environment in scientific funding, cross-disciplinary research, and Computing and
Experimental Technology.
We intend to develop and maintain the infrastructure necessary to foster an interdepartmental program,
building connections among faculty members across many departments on the Medical and Charles River
Campuses. We will continue to reach out to faculty members in new and emerging fields with the potential to
generate innovative approaches to human health through immunology, and provide valuable cross-disciplinary
training to future leaders in immunology. An integral part of this training will focus on research integrity, the
proper conduct of scientific investigation, and ethical treatment of others.
We will continue to recruit outstanding young students committed to careers in basic, translational, and
clinical science, and provide attractive opportunities to students from disadvantaged backgrounds—women
and underrepresented minorities in particular.
We will continually monitor trainee progress, and the effectiveness of the program overall, and take
whatever actions are necessary to ensure success individually and collectively.

Public health relevance
Narrative A functioning, well-regulated immune system is essential for the health and wellbeing of each person individually, and collectively. The system is extraordinarily complex, but great advances are being made at an accelerated pace that have tremendous positive impact on people’s health now, through such interventions as vaccines and cancer therapies, as well as enormous promise for greater health gains in the future. Our goal in undertaking the training activities described in this grant proposal is to train the next generation of reseach immunologists in technical skill, scientific judgment, and responsible conduct to become leaders capable of fulfilling the promise of immunological research.